COVID SARS-CoV-2 Assessment Viral Evolution (SAVE) VARIANT TESTING

COVID SARS-CoV-2 Assessment Viral Evolution (SAVE) variant testing provides support for analysis of SARS-CoV-2 genome sequences from specimens collected in COVID-19 therapeutic and observational trials for genetic variants that could impact diagnostics, therapeutics, vaccine efficacy, and disease severity. COVID SAVE provides support for the analysis of the impact of SARS-CoV-2 variants on disease severity in animal models and in vitro neutralization assays. Additionally, COVID SAVE variant testing allows analysis of the evolution of SARS-CoV-2 and identification of future variants with potential public health impacts.